Red Blood Cell BPGM Deficiency Contributes to Cognitive Impairment Following Ischemic Stroke

Project Summary/Abstract
Cognitive impairment (CI) affects up to 60% of stroke survivors, significantly impacting morbidity and mortality
after stroke. Understanding the mechanisms underlying CI following stroke is crucial for early diagnosis and
interventions, potentially slowing or preventing the progression of cognitive decline. Our pilot study identified
has identified red blood cells (RBCs) as a novel CI risk factor among stroke patients. The levels of the RBC-
specific enzyme, bisphosphoglycerate mutase (BPGM), were notably lower in stroke patients with CI compared
to those with normal cognitive function. BPGM plays a pivotal role in the glycolytic pathway within RBCs,
influencing the production of 2,3-bisphosphoglycerate (2,3-BPG). 2,3-BPG regulates hemoglobin affinity for
oxygen to ensure efficient oxygen delivery to tissues. The observed dysregulation of this process may
compromise oxygen supply to the brain, exacerbating hypoxic conditions following stroke. In line with this
notion, the hypoxia response in brain vascular cells was activated as a result of BPGM deficiency in RBCs.
Additionally, RBC BPGM may influence the vascular production of amyloid beta peptides (Aβ) and the integrity
of blood brain barrier (BBB). Therefore, we hypothesize that BPGM deficiency within RBCs may contribute to
CI in stroke individuals by inducing neurovascular dysfunction. In this R21 research, we aim to delve into the
intricate interplay between RBCs, brain vasculature and post stroke cognitive outcome. We will employ a
BPGM knockout (KO) mouse model to investigate how BPGM deficiency in RBCs contributes to CI after
stroke, and to explore potential therapeutic strategies, with a specific emphasis on the interaction between
RBCs and brain vascular system (Aim 1). Subsequently, we will assess the clinical relevance of RBC BPGM-
related metabolism by examining its association with post stroke cognitive outcomes in a larger patient cohort
(Aim 2). This research uniquely focuses on the overlooked connection between RBCs and vascular
dysfunction in the development of CI after stroke, introducing a novel avenue for investigating vascular
contributions to cognitive impairment and dementia (VCID). The findings from the study are anticipated to fill a
crucial knowledge gap and lay the foundation for innovative therapeutic interventions and potential clinical
applications.

Public health relevance
Project Narrative Cognitive decline is a major cause of disability and death among stroke survivors, yet the underlying mechanisms are not well understood. Our research seeks to uncover a new cellular process wherein abnormal red blood cells worsen cognitive deficits after stroke through their interaction with brain blood vessels. The discoveries from our study will contribute essential knowledge for early diagnosis and treatment options, ultimately improving the overall quality of life for stroke patients.